Mechanisms of Lipid Droplet Protein Targeting

Project Summary
LDs are essential organelles for lipid storage and metabolism. They are defined by a set of specific proteins on
their surface, many of which accumulate and are implicated in etiology of common human pathologies, such as
hepatic steatosis and cardiovascular disease.
Recent advancements in understanding lipid droplet (LD) biology, mostly derived from studying Drosophila cells,
have illuminated key aspects of protein targeting to LDs. However, key challenges remain in determining how
these pathways function in human cells, how physiologically important LD proteins (e.g., GPAT4 or ATGL) target
LDs and what the structural basis of LD protein targeting is. We have developed innovative methods to
investigate LD targeting mechanisms, including single-molecule analysis and new assays for studying protein
dynamics on LDs. We also will address the open question how proteins are removed from LDs under conditions
of LD turnover.
Findings from this work will address fundamental and yet unclear questions in cell biology. Since LD proteins
are targets for therapeutic intervention for prevalent diseases, this work may also pave the way for devising novel
therapeutic strategies against diseases linked to lipid dysregulation.

Public health relevance
Project Narrative Lipid storage in cellular organelles called lipid droplets (LDs) is important for cells and organisms to maintain energy homeostasis. Key for LD biology are proteins at their surface and alterations of LD surface proteins characterize and cause common diseases, such as obesity, fatty liver disease, and atherosclerosis. This proposal aims to unravel how proteins move to and from LDs, providing fundamental insights into cell biology and laying the groundwork for understanding therapeutic intervention.